Preclinical and clinical characterization of DNMT inhibitors +/- standard chemoimmunotherapy in TNBC

Given the heterogeneity and aggressiveness of TNBC, it is likely that successful novel targeted therapies will
continue to rely on identifying subsets of TNBC patients most likely to respond based on robust predictive
biomarkers. Compared to other subtypes, TNBC exhibits extensive epigenomic misregulation. In our preliminary
and published data, we identified a subset of TNBC with elevated DNA methyltransferase 3A (DNMT3A) that
exhibits unique sensitivity to DNMT inhibitors (DNMTi). We have shown that in TNBC, DNMTi induce degradation
of DNMTs through the E3 ligase TRAF6. We developed a DNMT3A IHC clinical assay and found that up to 80%
all TNBC tumors express DNMT3A, and ˜30% exhibit moderate-strong staining. DNMT3A+ was associated with
poor clinical outcomes independent of tumor stage, nodal metastases and immune infiltration. Building upon
our preliminary data, this proposal seeks to evaluate further the preclinical and clinical activity and
mechanisms of action of DNMTi + chemoimmunotherapy in DNMT3A+ TNBC, and to clinically evaluate
biomarkers with predictive and pharmacodynamic utility, with a focus on DNMT3A IHC and other
biomarkers in relevant pathways. Historically, enthusiasm for DNMTi has been hampered by limited efficacy
in previous clinical trials, mostly in ER+ breast cancer. There is little clinical information on these agents in TNBC.
Emerging evidence and our preclinical data suggest that DNMTi exhibit combinatorial effects with taxanes and
immunotherapy. We hypothesized that the addition of DNMTi to chemoimmunotherapy would be beneficial in
patients with DNMT3A+ TNBC. At the mechanistic level, although identified as a major mechanism of
DNMTi action, how the viral mimicry pathway regulates DNMTi activity in TNBC remains unclear and
requires further elucidation. Our preliminary data identified ZNF101 as a new regulator of the viral mimicry
pathway to regulate IFN-induced gene expression in TNBC. Our proposed Aims are intended to further evaluate
biomarkers and mechanisms of drug action in samples collected from a prospective phase I trial supported
through the NCI CTEP (NCT05673200), where we are evaluating an oral DNMTi (ASTX727) in combination with
paclitaxel and pembrolizumab in patients with metastatic TNBC, including the subset of DNMT3A high tumors
(Aim 1), and to evaluate ZNF101 and viral mimicry pathway involvement in anti-tumor activity (Aim 2) and anti-
tumor immunity induced by DNMTis (Aim 3). The results will be further tested in biospecimens collected from a
completed trial, NCT02957968, which evaluated IV decitabine + paclitaxel and pembrolizumab. While DNMTi
have been evaluated before in unselected breast cancer, the innovation in our project is the biomarker-driven
approach based on novel mechanisms of action described by our group. If successful, our finding will significantly
impact a large number of TNBC patients, as it may allow us to: (1) Gain novel insights into DNMTi activity in
TNBC, (2) repurpose DNMTi in patients most likely to benefit based on biomarkers and (3) enhance the
therapeutic efficacy especially in metastatic TNBC patients who have progressed on standard of care.

Public health relevance
TNBC is the most aggressive breast cancer subtype with limited treatment option, of which including the recently approved immune checkpoint blocker. Using both in vitro and in vivo preclinical models, we have identified that DNMT inhibitors (DNMTi), although showing less efficacy in previous studies are highly effective mostly in selected patients with high tumor DNMT expression and we also show that DNMTi can synergize with chemotherapy, paclitaxel and anti-PD-L1 antibody to significantly inhibit tumor grow. Therefore, in the current study, we plan to further understand the process by which DNMTi might affect tumor cell growth as well as anti-tumor immunity, leading to additional therapeutic strategies for TNBC with specific biomarkers that we will test in our prospective clinical trial.